Pathways for Physician Scientist Training in Psychiatric Research

Abstract
Physician-scientists serve a critical role in helping bridge the gap between basic and translational research and
as noted in PAR-20-094 “bring a unique perspective to research through [a] blend of clinical and research
experiences.” Thus training Psychiatrists for future careers as physician-scientists is significant and aligns well
with NIMH priorities to “strive for prevention and cures” and “increase the public health impact of research.”
This proposal seeks to recruit 2 promising physician scientists per year, with careful attention to diversity, into
the Pathways-RRT, a longitudinal research program within the University of Colorado Psychiatry residency.
The Pathways-RRT allows residents to complete all ACGME requirements for on time graduation and to sit for
board certification, while also creating individualized pathways for research skills development and productivity
during residency. The program provides between 14 and 18 months of research-dedicated time across
residency (amount of time depends on whether applicants enter Child Fellowship training where they will
continue their research training). Residents will be recruited based on their qualifications, demonstrated
passion for research, and in part, upon their areas of interest being in sync with our current and growing pool of
outstanding primary research faculty mentors. Program participants receive structured didactics focusing on
research design, biostatistics, rigor and reproducibility, the ethical conduct of research, and grant writing. A
Pathways-RRT seminar offers opportunities for work-in-progress sessions and presentation of research results
(poster, oral) with faculty and peer feedback. PGY3/CRY1 Pathways-RRT residents have small grants
available to support data collection focusing on answering important questions and to serve as pilot data for
future grant applications. The program offers close mentorship and utilizes individualized research plans,
collaborative mentoring teams, annual progress reports, surveys of residents and program faculty to evaluate
program strengths and weaknesses to foster continuous program improvement. Participants benefit from
complementary institutional commitment including the Psychiatry Research Innovations services (a $360,000
per year commitment to provide participants research support including grants administration, research
operations, educational workshops, pilot grant opportunities, clinical research support, and biostatistics). The
program seeks to prepare residents to compete for post-doctoral research fellowships and grant funding (e.g.,
NRSA, R21, K) and to prepare them to assume faculty positions at strong academic institutions pursuing
research-oriented careers. Thus, the program seeks to address the dearth of physician-scientists in Psychiatry
and to produce actionable resident-derived research products that enhance knowledge regarding the causes of
mental illness and improve clinical outcomes for patients.

Public health relevance
Project Narrative The Pathway-RRT seeks to recruit promising physician scientists into a longitudinal research program within the University of Colorado School of Medicine Psychiatry residency. The proposed program will create pathways for strong research productivity while still in residency and seeks to prepare our physician scientists to compete for post-doctoral research positions and future grant funding. We anticipate preparing program graduates to launch into academic careers thus increasing the workforce of physician scientists conducting translational research relevant to the priorities of NIMH.